IDENTIFICATION OF CHROMOSOME ARMS IN GENE EXPRESSION OF WHEAT HMW GLUTENINS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The objectives of the proposed research are to identify, map, and study the genes that regulate the expression of the high molecular weight (HMW) glutenin genes in bread wheat, Triticum aestivum L. The HMW glutenins play a key role in wheat baking quality. They also represent a valuable model system for studying the regulation of orthologous and paralogous genes in polyploid species, and the evolution of the regulatory systems controlling these genes. This project represents the first comprehensive search of the wheat genomes for genes regulating the transcription of the HMW glutenin genes.